Mapping RNA Binding Protein Interactions Within Cellular Microenvironments

PROJECT SUMMARY
RNA binding proteins (RBPs) play critical roles in all aspects of RNA metabolism, with significant implications in
physiological and pathological settings. A crucial factor in these processes is the exact location of these
RBP:RNA interactions within the cell. These interactions are pivotal when cells adapt to stress and are often
dysregulated in disease. Our current tools fall short in identifying RBP targets with subcellular resolution. This
proposal introduces a groundbreaking approach to bridge this knowledge gap. We aim to develop and apply
innovative tools designed to capture subcellular information for individual RBP:RNA binding events at a systems
scale within living cells. Using cellular models that mimic halted protein synthesis, we aim to build a
comprehensive spatial map of RBP:RNA interactions, shedding light on the remodeling of these networks during
changes in post-transcriptional and translational control. At the level of individual RBPs, we will explore the
temporal sequence of events by which specific RBPs regulate the localization, stability, and translation of their
target RNAs, especially during stress-induced relocalizations. Using cutting-edge proximity labeling and isolation
techniques, we will map RBP targets across subcellular space and integrate them within the broader landscape
of cellular RNA networks and interactions. These data will be analyzed using state-of-the-art computational
approaches and integrated with other high-throughput datasets such as Riboseq and RNAseq. This integrative
analysis will enable us to construct and iteratively test predictive models of RBP activity based on their spatial
distribution. Building off of this, we will apply these innovative methods to discern RBP:RNA regulatory programs
in difficult to isolate membrane-less organelles, using static and oscillating mammalian stress granules (SGs) as
our investigative platform. Overall, this proposal lays the foundation for an advanced understanding of RBP
models that incorporate subcellular location as a critical determinant of their functions. Our comprehensive
approach, bridging experimental and computational analyses, promises to uncover novel mechanisms of RBP
action during changing cell states, providing insights that may guide future therapeutic strategies against an
array of RBP-associated diseases that impact human health.

Public health relevance
PROJECT NARRATIVE RNA binding proteins (RBPs) help manage cell functions by interacting with RNA in specific locations within cells, and these interactions can change, especially under stress or in disease. Current techniques struggle to pinpoint these interactions precisely inside cells. Our proposal outlines innovative methods to map these interactions, which could improve the understanding and treatment of diseases linked to RBP malfunctions.